Core A: Administrative Core

The Administrative Core will provide the critical infrastructure and facilitation to integrate the research projects among themselves and with the community out reach and translation core, building upon the existing rich basic science and clinical resources at UCSF. This will be done by providing administrative support to the overall PEEC Formative Center and faciliating communication, both through the children's clinical health expert and by facilitating communication and interactions of the PEEC Formative Center. It will also support mentoring of new researchers in the field, and facilitate the migration of established researchers from biological and clinical sciences into the environmental health sciences. Finally, it will track the progress of the Formative Center toward reaching its goals and providing support as necessary to ensure success. It will foster multidisciplinary research and innovative methodologies and technologies and will greatly advance the field of children's environmental health research.

Public health relevance
Provide adminstrative support to the PEEC Formative Center. Facilitate the communication and interactions among the Formative Center scientists and with the COTC and outside groups. Support mentoring of new researchers and migration of established researchers into children's environmental health. Track progress of the Formative Center to achieve its goals.